Onco-primary care networking to support TEAM-based care - the ONE TEAM Study Supplement

Summary of Work The overall objective of this proposal is to identify factors associated with cardiovascular complications ?90 days of cancer surgery among older adults with solid tumors and elicit the perspectives of PCPs on the quality of communication with surgical providers following patients’ surgery. Our central hypothesis is that older adults with solid tumors who are at increased risk of cardiovascular complications are identifiable early in the perioperative period and that potentially modifiable factors in care coordination (such as having a PCP, early post-discharge follow-up with PCP, direct communication with PCP) are associated with lower rates of cardiovascular complications 90-days post-surgery.

Public health relevance
In 2006, the Institute of Medicine (IOM) released the seminal report, From Cancer Patient to Cancer Survivor: Lost in Transition. In the 13 years since, there has been substantial progress in understanding the health issues affecting cancer survivors, yet little has changed regarding survivorship care delivery. Methods to optimize the management of cancer survivors who are completing therapy and transitioning to follow-up care remain understudied. Notably, the cancer patient’s primary care provider (PCP) is generally not well-integrated in the cancer care team. This disconnect between primary and oncology care has led to problems in implementing risk- stratified survivorship care. Survivors with low or intermediate risk for cancer recurrence lose their way back to primary care - and thus survivors are still “lost in transition”. Concurrent with this lack of progress in improving health care delivery for survivors, there has been a rapid increase in the population of survivors that is straining the U.S. health care system. Since the IOM report, the number of cancer survivors has increased by 67% to 16.9 million. In the face of this growth, there are significant workforce shortages in oncology and primary care, and potentially insufficient healthcare dollars to support survivorship needs. With advances in cancer therapy and improved survival rates, the risk of death from cardiovascular disease (CVD) now exceeds the risk from cancer for many survivors. While cancer therapy may contribute to CVD-mortality risk, it is generally a combination of non- modifiable factors (i.e., genetics, aging), as well as modifiable lifestyle behaviors (i.e., diet, exercise) that lead to both cancer and CVD. Two “usual care” practices further exacerbate the risk of CVD. First, while trained in internal medicine, time constraints and difficulty keeping up with rapidly evolving non-cancer therapeutics make it increasingly difficult for medical oncologists to pay close attention to non-cancer-related comorbidities. Second, the lack of PCP integration in the cancer care team infers a lower priority for comorbidity management as long it does not interrupt cancer therapies, with a consequent decrease in adherence to chronic medications during and after therapy. We posit that to optimize care for cancer survivors within a value-based health care system, the patient’s PCP must become an integrated member of the cancer care team during and after cancer therapy and be empowered to manage non-cancer comorbidities. Further, we posit that having the PCP involved throughout cancer therapy will demystify the acute phase of cancer care for the PCP, familiarize the PCP with the patient’s clinical course and treatment-related health care needs, strengthen PCP-oncologist-patient communication, and enhance downstream survivorship care. Lastly, we posit that optimizing care will require multi-level strategies. Thus, we propose the ONE TEAM Study, an 18-month, cluster randomized controlled trial of a self-guided multi-level intervention (iGuide) using a sequential multiple assignment randomized trial (SMART) design. The trial will include a second randomization for the intervention group using a dynamic treatment regime (iGuide2). We propose to randomize 800 adults with newly-diagnosed select cancers treated with curative intent (breast, prostate, colorectal, endometrial, head/neck, and non-small cell lung cancer) and >1 select CVD comorbidity (hypertension, type 2 diabetes mellitus, hypercholesterolemia). Participants will be enrolled through the Duke Cancer Institute and two community-based cancer centers, all of which serve sociodemographically diverse populations. The unit of randomization will be the PCP clinic with ~80 PCP clinics across North Carolina involved in the study. The primary unit of analysis will be the patient. Primary aim: Determine the effectiveness of the self-guided multi-level iGuide intervention and the tailored/targeted iGuide2 intervention compared with usual care on meaningful endpoints: (1) Healthcare Effectiveness Data and Information Set (HEDIS) quality measures of management of the three CVD comorbidities based upon laboratory and clinical measurement; (2) medication adherence assessed via pharmacy refill data using Proportion of Days Covered (PDC); and (3) patient- provider communication (Patient-Centered Communication in Cancer Care). Hypotheses: Compared to usual care, cancer survivors randomized to the multi-level iGuide intervention will have significantly higher quality measures of CVD comorbidity management and medication adherence and will report better communication with their providers. Further, PCP clinics (and patients) who do not respond to iGuide will have significantly higher quality measures of CVD comorbidity management with an up-titrated iGuide2 multi-level intervention. 2o aims: Determine the effectiveness of iGuide and iGuide2 on supporting patient- centered outcomes (patient activation, care coordination, barriers to medication adherence, and financial toxicity), health care use (outpatient/emergency department visits, hospital days), measures of provider activation, and costs of care (medical visits, laboratory, out-of-pocket costs, lost productivity). Identify moderating and mediating factors and specific components in each level of the intervention associated with the outcomes. Qualitatively evaluate the intervention components using patient, PCP, and oncologist interviews. Our overarching goal is to optimize the management and outcomes of individuals with cancer, both during and after treatment, and to develop a ‘low-touch’ multi-level intervention that can be generalized, adapted, and scaled in other health care systems with or without a survivorship clinic.